Neurodevelopment In HEU Children Exposed In Utero To Dolutegravir Or Efavirenz

PROJECT SUMMARY
The global population of HIV-uninfected children born following in utero exposure to HIV and ART has
grown to ~15 million, with more than 1 million HIV-exposed/uninfected (HEU) babies born each year.
With increased rates of early-childhood mortality and a range of medical morbidities, HEU children
comprise a vulnerable population. Of particular concern is the lack of neurodevelopmental and
social-emotional outcomes data following in utero exposure to some of the most commonly-
used maternal ARV regimens. Efavirenz (EFV) is one of the most widely-used ARVs worldwide,
including among women who are pregnant or may become pregnant. Many HIV programs are
currently rolling out dolutegravir (DTG) for use in first-line ART, despite the recent early signal for
neural tube defects with DTG from conception. However, no studies have evaluated whether in utero
exposure to DTG-based ART poses an independent threat to neurodevelopmental and/or social-
emotional outcomes in HEU children, and minimal data exist for EFV (or from older children). Our
aims are thus as follows: Aim 1: To assess and compare developmental outcomes
(neurodevelopment, psychosocial) at 2 years of age in HEU children exposed in utero to DTG-based
ARV vs. EFV-based ART; and to compare outcomes between HEU children in each of these ARV
exposure groups vs. HIV-unexposed toddlers. Aim 2: To undertake the same comparisons of ND
and social-emotional outcomes as in Aim 1, but at 5 years of age, and with additional targeted
assessment in these school-age children of domains that are more predictive of future functioning
(e.g., executive function). Aim 3: To assess (over time) and compare depression, anxiety, and sleep
problem scores in women taking DTG-based ART vs. EFV-based ART (and women living with HIV
vs. HIV-negative women).

Public health relevance
PROJECT NARRATIVE Since 2010, as rates of new pediatric HIV infections have dropped by nearly half, the global population of HIV- uninfected infants born following in utero exposure to HIV and antiretroviral drugs has grown to ~15 million, with more than 1 million HIV-exposed/uninfected (HEU) infants born each year. Data on the short- and longer- range neurodevelopmental and emotional outcomes of HEU children are limited; and, indeed, for HEU children exposed in utero to either efavirenz- or dolutegravir-based antiretroviral treatment (ART) regimens – two of the most widely-used ART regimens worldwide – almost no data exist. In this longitudinal study, we will 1) assess 2- and 5-year neurodevelopmental and emotional outcomes of HEU children in Botswana who were exposed in utero to either efavirenz or dolutegravir, and 2) examine mental health and sleep characteristics in their mothers.